Interdisciplinary Training Program in Cardiovascular and Pulmonary Biostatistics

DESCRIPTION (provided by applicant): PROJECT SUMMARY/ABSTRACT Advances throughout the biomedical sciences rely to an increasing degree on the principles and methods of statistical analysis. The ability of a lab or clinic to generate data often outpaces its ability to fully analyze that data; and this can limit research progress. Being a science concerned with the collection, analysis, and interpretation of data itself, statistics will play a critical role in resolving the information bottleneck facing biomedical scientists. The research mission of our program is to pursue the most important problems at the interface between statistics and biomedical science - the problems of biostatistics. The aims of our interdisciplinary training program are to recruit and provide pre-doctoral training in cardiovascular and pulmonary biostatistics to talented students who are interested in careers in biomedical science. The demand is high for scientists with this expertise. In contrast with traditional biostatistics training, the proposed program will emphasize and further support the interdisciplinary elements of biostatistical research. Through course work, pre-doctoral trainees will learn theoretical, methodological, and practical underpinnings of statistics, and also relevant topics in biology, bioinformatics, clinical investigation, population-based investigation, and the responsible conduct of research. In a novel lab rotation system, trainees will become familiar with the biomedical context surrounding active investigations. Those who succeed in the program will be well positioned for further success in academia, government or industry. Contributing to the program are leading research/training departments, a high level of collaborative research across many disciplines, and a proactive approach to increasing the domestic supply of undergraduates through summer internship programs. We know that biostatistics has a critical role to play in modern cardiovascular and pulmonary medical science, and so we have designed an interdisciplinary training program to most effectively train the next generation of biostatisticians.

Public health relevance
PROJECT NARRATIVE Biostatistics is a fundamental scientific component of biomedical, public health and health services research, providing expertise in the design, monitoring ,and conduct, and leading the analysis of resulting data. While biostatistics expertise is paramount to the success of research initiatives, the current demand for biostatisticians far exceeds the supply and the gap is expected to continue to widen, accelerated by recent developments in genomics. The Interdisciplinary Training Program in Cardiovascular and Pulmonary Biostatistics will use an interdisciplinary approach to train the next generation of doctoral level biostatisticians, building upon our collaborations with researchers in cardiovascular and pulmonary medicine.